University of Colorado Rocky Mountain NeuroNEXT (UNCOMON) Clinical Research Consortium.

Effective clinical research into rare and ultra-rare neurologic and neurogenetic disorders requires a nationwide, collaborative network of neuroscience clinical research centers. The objective of the proposed University of Rocky Mountain NeuroNEXT Clinical Research Consortium (UNCOMON CRC) is to integrate expert from adult and child neurology, neurosurgery, neuroimaging, neuropsychology, and neurogenetics both the University of Colorado Hospital and Children's Hospital of Colorado on the University of Colorado Medical Campus into a large collaborative clinical research enterprise that exceeds start-up, retention, and operational goals of the NeuroNEXT network. The UNCOMON CRC is composed of recognized leaders in clinical research who have successfully participated in federally funded and multi-center clinical trials as well as local investigator-initiated therapeutic and biorepository The UNCOMON CRC will employ established clinical research and educational resources in conjunction a robust clinical research infrastructure to efficiently contribute to the NeuroNEXT network and advance the and research careers of the next generation of junior faculty nd fellows. We plan to achieve our goal the execution of the following specific aims: Aim 1: To establish a leadership network consisting of study adult and pediatric research directors, career enhancement director, DEI recruitment specialist, clinical coordinator, NeuroNEXT fellow, and operations manager; Aim 2: To establish an UNCOMON clinical consortium of collaborative co-investigators from adult and child neurology, neurosurgery, neuropsychology, and neurogenetics that encompass all subspecialty fields of clinical Aim 3: To establish a referral network to optimize recruitment and enhance outreach to minority and rural populations; and Aim 4: To develop and execute clinical research training and enhancement programs f or young i investigators using the collective expertise of the UNCOMON CRC. UNCOMON CRC will work efficiently to accelerate site qualification and IRB approval, employ multiple to optimize subject recruitment and retention, and carefully monitor research operations to ensure data a quality.

Public health relevance
The University of Colorado Rocky Mountain NeuroNEXT Clinical Research Consortium (UNCOMON CRC) comprises a large group of adult and pediatric physicians from multiple hospitals across the Rocky Mountain region who are experienced leaders in the field of clinical neuroscience. The UNCOMON CRC possesses the infrastructure, clinical research personnel, and patient population to be a leading contributor to the network and help further our understanding and advance therapies for rare and genetic neurological across the age spectrum.